Exploring anti-sense RNAs in melanocyte transformation and melanoma formation

SUMMARY
In the last decade, noncoding RNAs (ncRNAs) have emerged as key regulators of various biological processes,
potentially impacting the development of diseases, including cancer. One class of ncRNAs, known as antisense
RNAs (asRNAs) are transcribed in the opposite orientation to and overlap with genes encoding protein-coding
mRNAs. Human cells harbor numerous asRNA, and we have discovered several that exhibit differential
expression during melanoma development. However, the molecular mechanisms underlying the functions of
asRNA, whether they regulate the overlapping sense transcript in cis or other genes in trans, are poorly
understood. Additionally, the contribution of asRNAs to melanomagenesis remains unknown, partly due to the
lack of a versatile genetic toolbox for modulating endogenous asRNA transcription and abundance. To address
this gap, we have developed genetic tools that enable stable modulation of candidate asRNA transcription and
abundance, which we will implement in this R21 proposal. Using these innovative tools, we aim to assess the
tumor suppressive potential of a specific asRNA that we hypothesize to suppress melanomagenesis. Through
comprehensive analysis of asRNA expression in benign melanocytes and malignant melanoma cells, we have
identified CDH3-AS1 as a promising candidate melanoma suppressor. Our study will investigate whether
deregulation of CDH3-AS1 promotes melanocyte transformation and melanoma malignancy in vitro and tumor
formation in xenograft models. Furthermore, we will delve into the molecular characterization of CDH3-AS1’s
tumor suppressor activity, with a particular focus on its regulation of the overlapping sense gene, CDH3, which
encodes the putative melanoma suppressor P-Cadherin. Through our proposed studies, we aim to demonstrate
the pivotal role of decreased CDH3-AS1 expression in driving melanomagenesis. Moreover, our experimental
framework will establish a flexible foundation for future investigations of asRNA associated with melanoma. By
shedding light on the functions and implications of melanoma-associated asRNAs, our research will contribute
to advancing the understanding and potential treatment of this complex disease.

Public health relevance
NARRATIVE The functions of antisense RNAs (asRNAs) - non-coding RNAs that typically overlap with protein coding genes in the opposite orientation - in cancer are largely unknown, in part due to the lack of versatile tools that modulate asRNAs in ways that perturb their various functions. We have developed a platform to modulate asRNA expression in melanoma. Using this platform, we will analyze the tumor suppressive potential of CDH3-AS1, which overlaps the CDH3 gene that encodes P-Cadherin, a putative melanoma suppressor.